Latent Luciferase

? DESCRIPTION (provided by applicant): Bioluminescence is a powerful, inexpensive, and non-invasive method to monitor gene expression, enzymatic activity, protein-protein interactions and response to therapeutics both in vitro and in vivo. However, bioluminescence requires the use of a luciferase derived from a small number of luminogenic organisms (e.g., fireflies), and is limited to applications and organisms where genetic manipulation is both possible and practical. In this exploratory/developmental grant, we will identify proteins in non-luminous species that are latent luciferases, capable of bioluminescent light emission when treated with an appropriate substrate. In support of this substrate-directed approach, we have identified a fruit fly protein that is revealed to be a luciferase when treated with a synthetic luciferin analog. This unprecedented result shows that the function of a protein can be fundamentally changed simply by modification of the substrate, rather than by mutation. Beyond the paradigm-shifting implications for the evolution and design of new enzymatic activities, the prospect that non-luminogenic organisms encode latent luciferases has transformative potential for the non-invasive optical imaging of endogenous processes, potentially enabling bioluminescence imaging in native cells and organisms without the need for the introduction of an exogenous luciferase.

Public health relevance
PUBLIC HEALTH RELEVANCE: Bioluminescence is a powerful, inexpensive, and non-invasive method to monitor gene expression, enzymatic activity, protein-protein interactions and response to therapeutics both in vitro and in vivo. However, this technique requires the use of a luciferase derived from a small number of bioluminescent organisms (e.g., fireflies), and is limited to applications and organisms where genetic manipulation is both possible and practical. In this exploratory/developmental grant, we will identify proteins that can enable bioluminescence imaging in native cells and organisms without the need for the introduction of an exogenous luciferase.